Supplement: The impact of Medicaid expansion on the rural mortality penalty in the United States (Postbac)

Project Summary (copied from Parent Grant)
Rural areas in the United States (U.S.) have exhibited higher mortality rates than urban areas since the late
1990s, a pattern known as the rural mortality penalty. Recent research has found that the rural mortality penalty
continues growing due to mortality associated with preventable causes (metabolic and cardiovascular causes,
alcohol use, and mental health). The expansion of Medicaid adopted by many states in the U.S. had the potential
to reduce death due to these and other causes by facilitating access to healthcare to people who were not eligible
under previous eligibility thresholds. While some state in the nation adopted this expansion, a process that
started in 2014, others rejected it. While the adoption/rejection of this expansion is well-documented, little is
known about the role the adoption of this policy at the state level impacted well-established demographic
phenomenon such as the rural mortality penalty. This project requests access to restricted data to produce
mortality rates for the population aged 19-64, by sex and by race/ethnicity to conduct a novel analysis of the
differences observed in the rural mortality penalty employing a difference-in-difference design. The project
evaluate whether the Medicaid expansion impacted the rural mortality penalty emphasizing the overall
population, and disparities by sex and race/ethnicity. The project will also be the first to explore whether the
COVID-19 pandemic impacted rural/urban mortality dynamics based on state-level adoption of the expansion of
Medicaid by 2020. The analytic approach will combine formal and mathematical demographic methods with
novel statistical models to evaluate the impact of the expansion of Medicaid in rural/urban mortality dynamics.
Findings from this project will illustrate the role that state-level policies have in shaping diverging or congruent
trajectories in mortality and in the face of the ongoing COVID-19 pandemic.

Public health relevance
Narrative This diversity supplement to R21AG083393 will provide funding for Mr. Michael Segovia, a rising scholar from an underrepresented group, to (1) conduct research related to the Parent Grant focusing on the interaction between rural/urban residential context and state-level policies for mid-age adults in line with NIA’s Strategic Goals B and F, (2) be exposed to theoretical frameworks that guide aging research, and (3) develop research skills. The candidate will also benefit from opportunities available through the numerous research centers and research activities occurring at the Pennsylvania State University. Mr. Segovia will be integrated into the Research Team and Penn State as a Postbaccalaureate Researcher.